LIVER BIOPSY ONE YEAR FOLLOWING DISTAL GASTRIC BYPASS

This study will verify the absence of microscopic evidence of hepatic damage even in the absence of abnormalities on liver function tests one year following distal gastric bypass.